Underdiagnosis of primary immunodeficiency disorders among racial and ethnic minorities: Recognize and Educate

PROJECT SUMMARY/ABSTRACT
Primary Immune Deficiency (PID) is a debilitating condition that affects one in 1,200 persons in the US.
Although PID has been historically perceived to predominantly affect non-Hispanic white population, emerging
evidence suggests stark disparities in the diagnosis of PID among racial and ethnic minorities. Of note, while
past reporting of PID found that the majority of patients were non-Hispanic whites, implementation of newborn
screening for certain types of PID found no difference in disease prevalence in any ethnic group. Differential
access to diagnostic testing and specialty care, as well as diagnostic bias rooted in the prevailing belief that
PID primarily affects non-Hispanic white population, may have contributed to the underdiagnosis of PID among
minority populations. To date, there remains scant data on the risk factors of diagnostic delay in minority
patients with PID, and there are currently no published studies investigating impediments to diagnosis and how
they can be addressed. Delay in the treatment of PID can result in serious health problems, including organ
damage and death. There is therefore an urgent need to address disparities in the diagnosis of PID.
Our long-term goal is to improve timely diagnosis and treatment of PID in underserved populations. To achieve
this goal, we propose the following specific aims: (1) Identify patterns of diagnostic delay in PID among racial
and ethnic minorities; (2) Identify barriers to early diagnosis of PID among racial and ethnic minorities; and (3)
pilot a targeted intervention to improve awareness of disparities in PID diagnosis. We will combine analyses of
electronic health record (EHR) data (Aim 1) with qualitative analysis of patients’ lived experience and real-
world perspectives from healthcare providers to understanding barriers to early diagnosis of PID (Aim 2).
Additionally, we will apply advanced machine learning analysis as an innovative approach to enable a more
comprehensive understanding of the patterns of diagnostic delay. PID is a complex group of diseases with
highly variable clinical manifestations. We anticipate that the application of machine learning methods to EHR
data can facilitate identification of under-recognized patterns of diagnostic delay and will enable us to learn
from large clinical datasets in a scalable manner. Integrating knowledge from these analyses, we will then
develop and evaluate an educational outreach program targeting healthcare providers to raise awareness of
the disparities in PID diagnosis experienced by minority groups (Aim 3). The study will be conducted at 2 major
healthcare systems in Massachusetts: Mass General Brigham and Boston Medical Center.
This body of work represents the first systematic effort to investigate the patterns of, and barriers to, early
recognition of PID among minority populations in the US. To the best of our knowledge, the proposed pilot
educational outreach program will be the first educational initiative aimed at addressing PID diagnostic
disparities in the US, and will provide a foundation towards our longer-term goal of designing and developing a
regional/national educational program to improve diagnosis of PID among minority populations.

Public health relevance
PROJECT NARRATIVE Knowledge generated from the proposed research will provide an evidence base for addressing disparities in the diagnosis of primary immune deficiency (PID) among racial and ethnic minorities. Because early diagnosis and treatment of PID are crucial for the prevention of permanent organ damage and death, addressing disparities in PID diagnosis will have a significant public health impact and is relevant to NIMHD’s mission to improve minority health and reduce health disparities.